The Impact of Tissue Sialylation on Macrophage Polarization and Function

Summary
Tissue-resident macrophages play important roles in maintain tissue homeostasis. They broadly fall into two
categories: classically-activated and pro-inflammatory macrophages (M1) and alternatively-activated and anti-
inflammatory macrophages (M2). Within immune privileged tissues, such as the lung and liver, macrophages,
such as liver Kupffer cells, are typically described as M2. Our preliminary data suggests that the M2 phenotype
in the liver depends at least in part upon the glycome of the surrounding parenchyma, particularly the
hepatocytes. We have found that α2,6-linked sialic acids upon hepatocyte surface glycans promotes normal M2
polarization, but that loss of this sialylation drives M1 polarization and subsequent aberrant T cell activation
which leads to increased inflammatory disease susceptibility. In this proposal, we seek to determine the
mechanism by which α2,6-sialylated glycans in the liver drives changes in resident macrophage phenotype and
T cell activation. The proposed studies are broken into three aims, with the first two focused upon the influence
of α2,6-sialylated glycans on macrophage function and signaling, and the third focused upon the mechanism
underlying increased T cell activation and disease in the absence of sialylation. We believe that these studies
will introduce a novel immune checkpoint receptor which binds sialylated glycans, inhibits signal transduction,
promotes M2 polarization, and leads to immune homeostasis.

Public health relevance
Project Narrative Macrophages are integral tissue-resident immune cells that play critical roles in the immunologic health of most tissues. This research is based upon our preliminary discovery of a novel immune checkpoint receptor that appears to limit immune responses in immune privileged tissues as a function of the tissue glycome. This holds exciting significance because it is possible that this new checkpoint may impact not only immune homeostasis and the development of inflammatory disease, but also immune evasion in solid tumors.